IGF::OT::IGF TASK ORDER 1 - CORE & ADMINISTRATION; MAINTENANCE & INSTALLATION FOR THE SURVEILLANCE EPIDEMIOLOGY AND END RESULTS (SEER) ELECTRONIC DATA CAPTURE SOFTWARE SUPPORT AND INSTALLATIONS.

Surveillance Epidemiology and End Results (SEER) Electronic Data Capture Software Support and Installations.